Perspectives of Female Veterans, VHA Providers, and Family Members on Preventing Firearm-Inflicted Suicides among Female Veterans

BACKGROUND: In 2017, the age-adjusted suicide rate for female Veterans was 2.2 times that of female non-
Veterans. This may relate to a substantial increase in the proportion of female Veterans using firearms as their
means of death, particularly among women using Veterans Health Administration (VHA) care. Firearms are now
the leading means of suicide among female Veterans. Lethal means safety (LMS; i.e., reducing access to lethal
means when suicide risk is elevated) is a highly-recommended suicide prevention strategy. Yet prior firearm
LMS research has primarily focused on male Veterans, despite female Veterans idiographically differing in their
firearm access, ownership, and use. Data suggest that female Veterans more often obtain firearms and store
them loaded and nearby to increase safety following interpersonal violence (e.g., sexual assault, intimate partner
violence). Given high rates of interpersonal violence among female Veterans, it is critical to ensure firearm LMS
efforts are tailored and delivered to female Veterans from a trauma-focused lens. Further, nearly 40% of female
Veterans report having household firearms that they do not personally own, which often occurs through spouses
or partners. Thus, including family members in firearm LMS efforts may be particularly important for female
Veterans. Prior research also suggests that Veterans rarely initiate firearm discussions with their VHA providers,
who seldomly assess firearm access, despite its association with suicide risk. Thus, a multi-systemic perspective
that encompasses the perspectives of female Veterans, their spouses or partners, and VHA providers is
essential. SIGNIFICANCE/IMPACT: Effective suicide prevention necessitates a well-informed, patient-centered
approach. Yet firearm knowledge specific to female Veterans remains limited and has largely relied upon
extrapolating data from male Veterans. By understanding the experiences and perspectives of female Veterans,
their spouses/partners, and VHA providers, findings will inform development of gender-sensitive conceptual
understanding and interventions for approaching firearm LMS in this population. Findings can be used to
delineate a tailored firearm LMS intervention for female Veterans that can subsequently be piloted for
acceptability, feasibility, and ultimately efficacy. INNOVATION: This study is innovative in its focus on
understanding the inherent needs and preferences of female Veterans, rather than extrapolating findings from
male Veterans. It will be the first to interview female Veterans, spouses and partners, and VHA providers
regarding experiences and preferences for firearm LMS. This is highly innovative as spouses and partners have
rarely been included in Veteran suicide prevention research, despite increasing the likelihood of female Veterans’
firearm access. Findings are expected to result in knowledge essential for developing a gender-specific
conceptualization and intervention for addressing firearm LMS with female Veterans to ultimately provide a
patient-centered approach to a high-priority, understudied problem. SPECIFIC AIMS: Our aims are to: (1)
Describe female Veterans’ experiences, perspectives, and preferences regarding firearm access and LMS, and
explore the role of interpersonal violence within this; (2) Explore the perspectives and experiences of female
Veterans’ partners and spouses regarding engaging in firearm LMS (e.g., ability, willingness); and (3) Describe
VHA mental health (MH) and primary care (PC) providers’ experiences and perspectives on discussing firearm
access and LMS with female Veterans, including challenges and facilitators. METHODOLOGY: Qualitative
interviews will be conducted with: female Veterans who own firearm(s) or reside in a household with firearm(s)
and have experienced suicidal ideation or attempt (Aim 1); partners and spouses of female Veterans (Aim 2);
and VHA MH and PC providers who work with female Veterans (Aim 3). IMPLEMENTATION/NEXT STEPS:
Results will be synthesized to develop a patient-centered, gender-sensitive firearm LMS intervention for female
Veterans, and resources for family members and VHA providers. Key operations partners will be engaged in this
process to ensure feasible recommendations and wide dissemination of findings.

Public health relevance
Female Veterans are twice as likely to die by suicide, compared to female non-Veterans, and most commonly use firearms as their method of suicide. Lethal means safety (LMS; i.e., temporarily reducing access to lethal means) is recommended to prevent suicide. However, efforts primarily focus on male Veterans, whose firearm experiences and needs differ from female Veterans. LMS for female Veterans likely requires a systemic approach involving partners and providers. This study will: (1) describe female Veterans’ experiences, perspectives, and preferences regarding firearm LMS; (2) explore female Veterans’ partners’ perspectives and willingness to engage in firearm LMS; (3) understand VHA mental health (MH) and primary care (PC) providers’ perspectives and experiences of firearm LMS with female Veterans. Qualitative interviews will be conducted with female Veterans who have experienced suicidal ideation or attempt, female Veterans’ partners or spouses, and VHA MH and PC providers to inform a patient-centered, gender-sensitive approach to preventing firearm suicide.